Biostatistics and Bioinformatics Core

ABSTRACT
The goal of the Biostatistics and Bioinformatics Core (BBC) is to collaborate with Phase 2 Center
for Translational Viral Oncology (CTVO) investigators and other core scientists to enhance the
quality of the research undertaken by the junior principal investigators and pilot project directors
in the second phase of CTVO. The Core personnel have been selected because of their expertise
in relevant areas of Biostatistics and Bioinformatics that are pertinent to CTVO projects and that
foster teamwork in basic and translational research. The BBC will provide support in all stages of
the study, beginning with the formulation of the research questions, experimental design, data
collection, analysis, and interpretation, as well as writing of reports and dissemination of results.
Core personnel have played a significant role in planning and data analyses for the proposed
experimental plans in Phase 2 CTVO. The exact nature of the JPI/BBC collaboration will depend
on the scientific emphasis and the project needs. In addition to direct support of the projects and
other Cores, senior statisticians and bioinformaticians will also focus on the development of
statistical methods and bioinformatics tools related to the needs of the projects in the CTVO. To
achieve this goal, we will undertake the following Specific Aims: 1: Provide biostatistics and
bioinformatics support on study design of clinical, laboratory and genomic studies and
experiments for CTVO investigators; 2: Provide solutions and technology support services on
data management and analyses to CTVO investigators, and 3: Develop novel biostatistics and
bioinformatics methodology tools to address any issues that could not be addressed by existing
methods. The ultimate goal is to provide custom-made and innovative biostatistics and
bioinformatics support to successfully execute and complete the projects proposed in this Phase
2 CTVO grant renewal application.